AZT LEVELS IN PATIENTS RECEIVING BETASERON

AIDS patients who are receiving AZT and then have interferon administered will have altered metabolism of AZT with decreased blood levels being induced by interferon administration.